A Patient-Oriented Research Program in Geriatric Oncology

PROJECT SUMMARY
The principal investigator (PI), Dr. Supriya Mohile, of this K24 renewal proposal leads an independently funded
patient-oriented geriatric oncology research program at the University of Rochester Wilmot Cancer Institute.
Over the last K24 funding period, Dr. Mohile completed two large multi-site cluster-randomized trials that
evaluated whether geriatric assessment and management (GAM) improves outcomes of older patients with
advanced cancer. GAM, a validated patient-centered approach for assessing health status, identifies older
patients with cancer who are at risk of adverse outcomes and guides management for cancer treatment and for
aging-related conditions. Both trials demonstrated, for the first time, that a GAM intervention improves patient-
centered outcomes (communication and patient/caregiver satisfaction) and clinical outcomes (treatment
toxicity, falls, and polypharmacy). Integrally involved in this research, mentees at the University of Rochester
and through the Cancer and Aging Research Group (CARG) have utilized data from the GAM trials to
successfully compete for their own career development and independent awards. Of the ten early career
scientists that Dr. Mohile currently mentors at the University of Rochester, eight are women and four identify as
underrepresented in medicine. Mentees have received over 20 grants and have published over 80 manuscripts
with Dr. Mohile. Dr. Mohile is currently a primary mentor or co-mentor on seven career development awards.
Further, over the last K24 funding period, Dr. Mohile successfully competed for three new R-level awards as PI
from the Patient Centered Outcomes Research and the National Institutes of Health to evaluate strategies for
implementing GAM in oncology practices and to expand understanding about cancer treatment tolerability in
older adults. The original K24 allowed Dr. Mohile and her mentees to enhance skills in communication
research; the renewal will allow them to learn about implementation science and leadership with expert
consultants at the University of Rochester and in CARG. The overarching aims of this proposal are: 1) to
develop and evaluate implementation strategies for GAM in oncology practices; and 2) to examine treatment
tolerability in older patients with advanced cancer and aging-related conditions starting a new high-risk cancer
treatment regimen. This research will have a positive impact by providing information on pragmatic
mechanisms for implementing GAM in oncology care. Importantly, this proposal will allow for the career
development of mentees pursuing patient-oriented research focused on geriatric oncology, an understudied
field. Through funded research, an endowment from the Wilmot Cancer Institute, and the NIA-funded CARG
(MPI: Mohile), Dr. Mohile has the resources to continue to foster the careers of investigators interested in
geriatric oncology research across the academic career trajectory. The renewal of this K24 Award will enable
Dr. Mohile to expand mentoring to enhance the growth of patient-oriented research in geriatric oncology.

Public health relevance
PROJECT NARRATIVE Renewal of this K24 Mid-Career Award in Patient-Oriented Research would enable the Principal Investigator, Dr. Supriya Mohile, to expand her research skills and mentoring activities to further the growth of a patient- oriented research program in geriatric oncology. Her multi-site cluster randomized studies have demonstrated that a geriatric assessment and management (GAM) intervention improves patient-centered and clinical outcomes of older patients with advanced cancer and their caregivers. The overarching research goals of this proposal are to: 1) develop and evaluate implementation strategies for GAM in oncology practices and 2) examine treatment tolerability in older patients with advanced cancer and aging-related conditions starting a new high-risk cancer treatment regimen.